Calcium-related neurotoxicity of cocaine

2021 NIDA Summer Research Internship Program PI: Congwu Du Abstract/Project Summary: This ‘Summer Research with NIDA’ program will be hosted in the Dept. of Biomedical Engineering, Stony Brook University. One intern student, Madison McGuire (University of Florida) is selected by NIDA (General Submission document for details) , who will join us at Stony Brook as interns for summer research, 2021. Due to Covid-19, this internship will be offered virtually. She will join our lab between 06/01/2021 and 8/30/2021. She will work with a graduate student (Kichon Park, a daily mentor) to learn imaging process. I, Congwu Du, will function as a PI for this research/education activity. As a PI, I will stay in my lab during the summer and will meet the student daily or during group meeting. In addition, we will have graduate students, Ki to work with intern in a daily basis to ensure the progress of the research. By following NIDA program guideline, we need to submit a supplement application through PA- 20-272, so that the program will be able to support internship's stipend and mentor fee through our awarded R01 (DA029718).

Public health relevance
2021 NIDA Summer Research Internship Program PI: Congwu Du Project Narrative: This ‘Summer Research with NIDA’ program will be hosted in the Dept. of Biomedical Engineering, Stony Brook University. One intern student is selected by NIDA who will join us as interns for summer research, 2021. This supplement application will be able to support internship's stipend and mentor fee through our awarded R01 project.